Optimizing psychosocial intervention for breast cancer-related sexual morbidity: A factorial trial using the National Cancer Institute Community Oncology Research Program (NCORP) network

PROJECT SUMMARY/ABSTRACT
Approximately three-quarters of the 3.8 million breast cancer survivors in the U.S. experience clinically significant
sexual distress and dysfunction. This cancer-related sexual morbidity can be addressed by Internet interventions
that include multiple therapeutic techniques to target the overlapping biopsychosocial aspects of the problem;
however, the full potential impact of these interventions has yet to be realized due to high refusal rates from time
burden and high attrition rates. A more efficient sexual morbidity intervention that retains efficacy while lowering
participant burden would have greater public health impact. Therefore, the goal of this proposal is to determine
an Internet intervention that is optimized for greatest impact on breast cancer-related sexual morbidity, to
evaluate mediators and moderators of intervention component efficacy, and examine survivors’ engagement
with the intervention components. Specifically, we will test four research-tested and fully-automated Internet
intervention components for breast cancer survivors – psychoeducation about cancer-related sexual morbidity,
training for communication with their clinicians, training for communication with their partners, and physical
intimacy enhancement – using the Multiphase Optimization Strategy (MOST) research framework. We will recruit
320 intimately partnered women who have completed primary breast cancer treatment and report sexual
morbidity through the NCI Community Oncology Research Program (NCORP). In the highly-efficient optimization
trial, participants will be randomized to receive a combination of the four intervention components and will
complete online assessments at baseline (pre-randomization), 3-month post-assessment, and 6-month post-
assessment. For Aim 1, we determine the optimal breast cancer-related sexual morbidity intervention package
by following a systematic data-driven approach that tests intervention component effects both independently and
synergistically on sexual distress (primary outcome) and sexual functioning (secondary outcome). For Aim 2, we
will evaluate mediators (sexual functioning knowledge; sexual communication self-efficacy with providers and
with partners; relationship intimacy) and moderators (menopausal status at diagnosis; adjuvant endocrine
therapy use; metastatic disease; psychological distress; relationship duration and dissatisfaction) of intervention
component efficacy on sexual morbidity. Last, for Aim 3, we will examine survivors’ engagement and satisfaction
with the intervention components. As the first MOST study of cancer-related sexual morbidity, this study is
directly responsive to NOSI NOT-OD-20-106 and to calls from leaders in cancer control to advance intervention
science through systematically testing intervention components and their mechanisms. By identifying the
combination of sexual morbidity intervention components likely to provide breast cancer survivors the greatest
benefit for the least burden, this study will result in the first Internet intervention optimized for maximum impact
for the undertreated, prevalent, and devastating problem of breast cancer-related sexual morbidity.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as about 1 in 8 women in the U.S. will be diagnosed with breast cancer in her lifetime, and about 3 in 4 of those women will experience clinically significant sexual morbidity. Relevant to the mission of the NCI, this study aims to improve cancer care by establishing an Internet intervention that provides breast cancer survivors the greatest sexual health benefit for the least burden. Findings will also improve cancer-related sexual morbidity intervention science by evaluating how intervention components work, for whom they work best, and how they can be made more engaging.